Administrative Core

Objective The objective of the Administrative Core is to provide leadership, direction and administrative services for the purpose of enhancing research productivity and maintaining a stimulating research environment in reproductive biology. Through its interactions with investigators and their research groups, the Administrative Core fosters exchange of ideas and promotes collaboration. It monitors core activities and strives to improve the efficiency and effectiveness of the core facilities.